PEDIATRIC NEUROEPIDEMIOLOGY

Several studies in pediatric neuroepidemiology are ongoing: 1) analysis of case-control data for putative predictors of febrile seizures, based on a data set from six cities from the People's Republic of China has been completed; 2) The prenatal and perinatal antecedents of febrile seizures were examined in NINDS data; 3) With Yugoslav colleagues, we are examining the utility of the electroencephalogram as a predictor of recurrence of febrile seizures in a defined population in Yugoslavia; 4) NINDS participants were involved in the analysis of a randomized controlled clinical trial undertaken in the NICHD to evaluate the safety and efficacy of phototherapy in the prevention/reduction of hyperbilirubinemia in the neonate. We investigated the frequency of adverse neurologic outcomes at six years of age.